Integrated Female Sexually Transmitted Infection Testing for HIV Epidemic Control through PrEP: The IN-STEP study

PROJECT SUMMARY
Globally, new HIV infections are concentrated in eastern and southern Africa where they are largely acquired
by women outside of known key populations. Identifying African women at high risk for HIV acquisition and
successfully engaging them in HIV prevention services, particularly pre-exposure prophylaxis (PrEP)
programs, is an urgent global health priority. The U.S. President’s Emergency Plan for AIDS Relief program in
Africa typically relies on self-reported risk screening tools (SRST) to target HIV testing and refer individuals for
PrEP. However, these tools have low to moderate sensitivity, missing many women at high risk for HIV. This is
partly due to underreporting of risk factors, but also because many African women are at heightened HIV risk
solely through relationships with high-risk male partners. Moreover, many African women enrolled into PrEP
programs stop using PrEP within months of initiation. Decades of research shows that curable sexually
transmitted infections (cSTI) are objective markers of future HIV risk, but cSTI testing largely has been omitted
from African HIV programs. With the advent of lower cost multiplex cSTI testing and point of care diagnostics,
there is new opportunity to determine whether integrating female cSTI testing services into HIV programs can
improve HIV epidemic control. Here, we propose an individually randomized effectiveness implementation trial
of SRST plus cSTI diagnostic testing for chlamydia, gonorrhea, trichomonas, and syphilis compared to SRST
alone to increase PrEP use among cis-gender African women aged 15-39 years. We hypothesize that cSTI
testing will increase PrEP use primarily through (i) improved identification of women at high risk for HIV and (ii)
enhancement of self-perceived HIV risk. The proposed research will be nested within the Rakai Community
Cohort Study, a population-based HIV surveillance cohort in Uganda. In Aim 1, ~4,500 HIV-negative women
will be individually randomized 1:1 to PrEP screening based on SRST plus cSTI diagnostic testing
(intervention) versus PrEP screening based on SRST alone (control arm). Both arms will be offered syndromic
case management for cSTIs and syphilis testing for pregnant women (standard of care). The primary outcomes
will be PrEP uptake, adherence, and persistence, assessed through clinical records and drug level testing. In
Aim 2, we will perform a mixed-methods, implementation science evaluation of female cSTI testing for HIV
prevention and control. We will use qualitative and quantitative methods to assess the mechanisms, barriers,
and facilitators to improving PrEP outcomes through cSTI testing and how this varies by cSTI pathogen, SRST
outcomes, and demographic profiles. In Aim 3, we will use mathematical models to evaluate different cSTI
testing approaches to reduce HIV incidence at a population level by considering what cSTIs to screen for, in
what health care settings, and at what cost thresholds. We will also model broader health benefits of cSTI
testing. Results from this study will provide actionable, population-level information to inform strategic delivery
of high impact HIV prevention through integrated HIV and cSTI programming in Africa.

Public health relevance
PROJECT NARRATIVE Women living in eastern and southern Africa are at high risk for HIV, but effective use of oral pre-exposure prophylaxis (PrEP) for HIV prevention in this population is low. Integrating curable sexually transmitted infection (cSTI) testing for women into African HIV programs may improve PrEP uptake and use through (1) improved identification of women at high risk for HIV acquisition and (2) increased awareness of HIV susceptibility among those diagnosed with a cSTI. This study aims to conduct a randomized trial of cSTI testing to improve PrEP uptake and use among women at high risk of HIV in Uganda, with complementary mixed methods research and mathematical modelling for program optimization.